Research Project 2: Targetin Tumor-Initiating Cell (TIC) Heterogeneity To Overcome Chemotherapy Resistance

PROJECT SUMMARY
We and others have shown that a subset of tumor cells capable of regenerating new tumors, termed variously
as tumor-initiating cells (TIC) or “cancer stem cells” (CSC), are comparatively resistant to current systemic
chemo- and radio-therapies relative to the bulk of the tumor. As such, the guiding premise for our work over the
past decade, is that therapeutic targeting of processes required for survival or function of TIC will allow
elimination of such cells at both the primary and metastatic sites, thereby enhancing response to current
systemic therapies. However, it has become clear from several laboratories using current cell surface markers,
enzymatic activity markers, and lentiviral signaling reporters for Wnt, Hedgehog, and STAT3-mediated
signaling, that TIC are heterogeneous not only across tumors, but also show different behaviors, treatment
responses, and reporter gene expression at the primary and metastatic sites within a given tumor model. Thus,
it is critical to understand the diversity of TIC types both within and across tumors, as well as to understand
how such cells differ in function between the primary and metastatic site, in order to target them effectively –
particularly in “triple-negative” breast cancer (TNBC), for which there are no approved targeted therapies.
We hypothesize that there exist molecularly distinct classes of TIC in TNBC. As a consequence, differential
responses to individual chemotherapies depend, in part, on the class(es) of TIC present in a given tumor. If
true, we further assert that identifying and targeting class-specific TIC functions may help overcome
chemotherapy resistance.
In order to identify candidate regulatory genes or pathways functioning in a spectrum of PDX-derived TIC
isolated from primary and metastatic sites, we propose to determine first whether TIC derived from either the
primary or metastatic site show identical, or different, patterns of activation of signaling networks implicated in
TIC function using lentiviral fluorescent reporters specific for signaling pathways and transcription factors
implicated in TIC function. We will then identify candidate molecular mechanisms required for TIC activity at
the population and single cell levels using RNAseq.
In order to determine whether in vivo targeting of TIC-related genes/pathways can augment response to
carboplatin, and lead to elimination of different classes of TIC at both the primary and metastatic sites, we will
evaluate the ability of FDA-approved agents targeting TIC to augment treatment response alone or in
combination with carboplatin at the primary and metastatic sites, and assay the effect of treatment on TIC
function in vivo. Results may be used to guide planning and execution of human clinical trials and inform
precision medicine efforts.